A Dynamic Patient Data Library and Virtual Imaging Trial Platform for Training and Evaluating AI-based Algorithms in CT Imaging

PROJECT SUMMARY/ABSTRACT
Deep Learning Reconstruction and Noise Reduction (DLR) algorithms are increasingly used in CT
clinical practice, with substantial potential to reduce radiation dose and improve image quality.
However, their advancement is hindered by the lack of accurate diagnostic performance evaluation
tools and limited public CT projection data for training. These challenges create significant hurdles for
developers to optimize their algorithms and prove dose reductions, and for regulatory bodies and
clinical users to validate these claims, raising crucial safety concerns for millions of CT patients.
With prior funding support from the NIBIB, we created a CT patient projection data library in an open,
vendor-neutral format, DICOM-CTPD. This resource has been globally utilized by researchers to
develop, train, validate, and test various DLR algorithms, including those mark the beginning of AI
applications in CT imaging. Despite its great success, this library is constrained by its static dose
levels, disease conditions, and data from older scanner models.
These limitations highlight the pressing need for a new, dynamic patient projection data library with
advanced diagnostic performance evaluation tools. The objective of this project is to develop a
dynamic, customizable, vendor-neutral patient projection data library and software platform (DICOM-
CTPD-VIT). This platform will be capable of generating a diverse range of conditions in radiation
dose, reconstruction parameters, and lesion characteristics, and will facilitate automated image
quality and diagnostic performance evaluation. The project comprises three specific aims:
Aim 1: Develop a dynamic and vendor-neutral patient projection-data library with an integrated virtual-
imaging-trial (VIT) software platform (DICOM-CTPD-VIT).
Aim 2: Develop and validate a patient-data-based VIT evaluation framework for DLR methods.
Aim 3: Develop and validate VIT-based approaches to quantifying hallucinations in DLR methods.
The innovation and significance of this project lie in its dynamic, vendor-neutral patient projection data
library, integrated with a VIT, and a patient-data-based evaluation framework. These resources allow
for creation of varied imaging conditions, tailored to the needs of clinical users and researchers. It
provides pathways for both algorithm development and clinical evaluation, addressing the diverse
needs within the CT field to facilitate effective development and safe implementation of DLR methods
in clinical practice. Moreover, the platform has the potential to generate an unlimited number of cases
with ground truth, useful for training and evaluating other AI-based diagnostic tools beyond DLR.

Public health relevance
PROJECT NARRATIVE Our goal is to create a dynamic, vendor-neutral patient projection data library and software platform for training and evaluating AI-based reconstruction and noise reduction methods in CT. Designed with high customizability, this platform will enable dynamic adjustments in radiation dose and disease conditions and will provide automated capabilities for image quality and diagnostic performance evaluation.